Administrative Core

This core will provide the administrative support needed to integrate the projects into a coordinated Program. This will be accomplished by facilitating regular communication between the principal investigators and their collaborators in monthly conference calls and semi-annual meetings in Minnesota or Florida, and by scheduling interactions of the Pis with internal and external review committees. It is worth pointing out that while monthly meetings bringing together all members of the Program, Drs. Ranum or Day pick talk with Dr. Swanson by phone much more frequently and whenever we feel some aspect of the research would move forward more quickly by having a conversation.